Oral Streptococcal Fitness And Virulence genes

Project Summary
Streptococcus sanguinis is a commensal oral bacterium and a pioneer colonizer
of human teeth. It is associated with infective endocarditis and can enter the
bloodstream through oral lesions, invasive dental procedures or routine oral
activities such as chewing, flossing and brushing teeth. Recent developments in
genomic technologies have created an opportunity to study streptococcal fitness
genes as a whole by systems biology. This application proposes in Aim 1 to identify
genes required for S. sanguinis fitness in an infective endocarditis model by
screening a unique, comprehensive library of S. sanguinis genome-wide mutants.
In Aim 2, a comparable analysis will be performed in saliva, serum and blood using
ORF-seq analysis to clarify the findings of Aim 1 and to identify genes required for
fitness, but not growth in saliva. The fitness genes in saliva and blood will be
compared. Fitness genes that are located at critical hubs will be identified in
network analysis and those that are conserved among oral streptococci will be
identified by bioinformatics. In aim 3, the gene regulation of fitness genes will be
studied in depth. This systematic analysis will provide an unprecedented
understanding of streptococcal fitness genes at the molecular level and set the
stage for identification of specific targets for new therapeutics or prophylactics.

Public health relevance
Project Narrative Streptococcus sanguinis is a common bacterium in the mouth, where it is associated with oral health; however, if it enters the bloodstream through periodontal disease, routine activities such as chewing, or dental procedures, it can cause a serious infection of the heart called infective endocarditis. We propose to perform an unprecedented search for factors required by S. sanguinis to cause this disease with the goal of finding targets for a new kind of antibiotic that prevents disease, but can also be taken daily without promoting antibiotic resistance.